Mechanosignaling regulates macrophage immunometabolism

PROJECT SUMMARY
Pulmonary fibrosis is a class of disease conditions characterized by subacute and chronic progressive scarring
of the lungs. The most common form, idiopathic pulmonary fibrosis (IPF), has a prevalence of 1 in 200 among
people older than 65. IPF is a devastating disease with a median survival of 3 to 5 years with limited therapy to
halt its progression. Recent research had highlighted the critical role of macrophages, particularly monocyte-
derived macrophages (MDMs), in pulmonary fibrosis. Macrophages are highly plastic and undergo metabolic
reprogramming and alternative activation during fibrosis. The interactions of macrophages and their fibrotic
environment are crucial for fibrosis progression. Numerous studies have shown that different biochemical
signals can induce macrophage metabolic reprogramming and alternative activation; however, limited data are
available to demonstrate whether physical signals such as enhanced extracellular matrix (ECM) stiffness, the
cardinal changes during lung fibrosis, can modulate macrophage metabolic reprogramming and alternative
activation. Our preliminary data showed that macrophages cultured on matrix with stiffness similar to fibrotic
lungs (20 kPa) had increased PPARγ compared to macrophages cultured on a soft and compliant matrix with
stiffness similar to normal health lungs (0.5 kPa). Integrin β3 is increased in lung macrophages from human
subjects with pulmonary fibrosis and animal with experimental fibrosis. Mechanistically, we hypothesize that
macrophages utilize integrin β3 as the mechanosensor to activate PPARγ to modulate metabolic
reprogramming and alternative activation. In Aim 1, we will determine if ECM-stiffness regulates macrophage
metabolic reprogramming. In Aim 2, we will determine the mechanosignaling pathway utilized by macrophages
to modulate metabolic reprogramming. In Aim 3, we will test our hypothesis in an experimental pulmonary
fibrosis mice model to determine whether interrupting PPARγ-mediated mechanosignaling and metabolic
reprogramming in macrophages can attenuate pulmonary fibrosis in vivo. By completing this proposed study,
we aim to show that 1) macrophages sense ECM stiffness via Integrin αvβ3; 2) matrix stiffness can modulate
macrophage metabolism to sustain its alternative activation; 3) PPARγ is a mechanosensitive transcription
factor, and 4) inhibiting αvβ3-PPARγ mechanotransduction pathway in macrophages can attenuate pulmonary
fibrosis in vivo. I will utilize this proposal to acquire additional skills in the cutting-edge field of mechano-
immuno-metabolomics through a series of didactic and applied training under the mentorship of an
experienced multidisciplinary team. This K08 will facilitate my transition to an independent physician-scientist
studying the pathogenesis of pulmonary fibrosis, with a unique research niche of mechano-immuno-
metabolomics. This research proposal will also aid in identifying novel mechanisms and targets for therapies in
pulmonary fibrosis, which is fatal and with limited treatment.

Public health relevance
NARRATIVE Pulmonary fibrosis, the scarring process of the lung, is usually irreversible and potentially fatal. We propose experiments to determine how mechanical properties of the fibrotic environment modulate macrophage phenotype/immunity through metabolic reprogramming. These studies will lead to a greater understanding of the development of pulmonary fibrosis and provide novel therapeutic targets for drug development.